Epigenetic mechanisms of cognitive and nociceptive impairments in AUD

PROJECT SUMMARY
A significant number of individuals struggle to maintain sobriety as a result of withdrawal symptoms that emerge
during early abstinence from alcohol. While preclinical studies have focused on negative affective symptoms of
withdrawal, heightened pain sensitivity and cognitive impairment are also commonly reported during early
abstinence. Yet, the precise neurobiological mechanisms underlying these symptoms are not well-understood.
The medial prefrontal cortex (mPFC) is critically involved in cognition. Although less well-appreciated, this brain
region also plays an important role in regulating pain. During the current and previous funding period, we
uncovered a number of significant epigenetic and transcriptional changes in the mPFC of individuals with and
without alcohol use disorder (AUD). Merger of bulk RNA-seq results from mPFC of control and AUD subjects
with those from mPFC of control and withdrawn male and female rats revealed concordant differential expression
of genes regulating neuroimmune signaling and synaptic plasticity in AUD/withdrawn subjects. These results
were validated in a rodent model of alcohol dependence and our preliminary data points to an epigenetic
mechanism driving the observed changes in gene expression. Importantly, these changes occur at the same
period of withdrawal during which we also observe deficits in decision making and hyperalgesia. Altogether,
these data lead us to hypothesize that epigenetic dysregulation of the expression of key genes in the mPFC that
mediate neuroimmune signaling and synaptic plasticity promotes neuroadaptations that facilitate cognitive and
nociceptive symptoms of withdrawal. Experiments in the current proposal are designed to test this hypothesis
by determining the cell-type specificity of epigenomic and transcriptomic changes and subsequently leveraging
a gene editing approach (CRISPR-dCas9) to reverse cell-type-specific withdrawal-induced epigenetic
modifications. The effect of dCas9-mediated reversal of withdrawal-induced effects on mPFC physiology, cell
morphology, and behavioral symptoms of withdrawal will be measured in a rodent model of AUD and findings
will be translated by validating the observed changes in postmortem mPFC from individuals with and without
AUD. Results from these experiments will provide new insight into the neurobiological mechanisms underlying
AUD and have the potential to uncover new targets for the development of pharmacotherapeutics aimed at
treating symptoms of withdrawal in individuals with AUD.

Public health relevance
PROJECT NARRATIVE The neurobiological mechanisms underlying symptoms of withdrawal are poorly understood despite the fact that they serve as potent triggers for relapse in individuals attempting to remain abstinent from alcohol. While our recent work uncovered significant epigenetic and transcriptional changes in the mPFC of individuals with and without AUD, the relationship between such changes and symptoms of withdrawal is unclear. The proposed project will use a rodent model of alcohol dependence to causally link epigenetic dysregulation of key genes in the mPFC with cognitive and nociceptive symptoms of withdrawal and in doing so has the potential to identify new therapeutic targets for the development of drugs to treat withdrawal symptoms.